Investigating the direct reprogramming of fibroblasts into skeletal muscle progenitors

SUMMARY
Transdifferentiation denotes the conversion of one mature cell type into another mature cell upon forced
expression of transcription factors or treatment with small molecules. Transdifferentiation systems typically give
rise to postmitotic cells, which poses a challenge for mechanistic studies and potential therapeutic applications.
To address this shortcoming in the muscle lineage, we recently developed a novel strategy to dedifferentiate
fibroblasts directly into “induced myogenic progenitor cells” (iMPCs) by transiently expressing the myogenic
transcription factor MyoD in the presence of three small molecules. iMPC cultures are comprised of stem-like
cells that give rise to progenitors and mature myofibers exhibiting spontaneous contraction, thus recapitulating
key stages of myogenesis in a dish. Moreover, stem-like iMPC subsets can be clonally propagated for at least
20 passages while retaining the ability to produce myotubes, demonstrating long-term self-renewal and
differentiation potential in vitro. Accordingly, bulk iMPCs transplanted into mdx dystrophic mice engraft and
differentiate into Dystrophin-expressing myotubes in vivo. Thus, our results represent the first successful
derivation of stable, expandable and functional muscle stem-like cells directly from fibroblasts and provide the
basis for this R01 application using three complementary aims. In SPECIFIC AIM 1, we will compare molecular
and functional properties between Pax7+ stem-like cells purified from iMPC cultures and Pax7+ satellite cells
purified from skeletal muscle using single-cell expression and chromatin analyses as well as a serial
transplantation assay. In addition, we will leverage a tetO-MyoD mouse we recently developed to test whether
different cell types are equally amenable to dedifferentiation into iMPCs and whether iMPCs derived from distinct
cell types retain a transcriptional memory from their cells of origin. In SPECIFIC AIM 2, we will investigate the
molecular mechanisms underlying this dedifferentiation process. First, we will assess whether the establishment
and maintenance of iMPCs depend on the same genetic regulators as satellite cells in vivo, with a focus on the
transcription factors Pax7, Myf5 and MyoD including MyoD mutants with altered DNA and cofactor binding. We
will further explore the specific roles of MyoD and small molecules during iMPC induction by examining enhancer
and gene expression dynamics in relation to transdifferentiation (MyoD alone). In SPECIFIC AIM 3, we will test
the potential therapeutic utility of iMPCs using mouse and human cells. Briefly, we will assess whether iMPCs
from dystrophic mdx mice recapitulate published disease phenotypes in vitro and whether iMPCs are susceptible
to gene therapy. Mechanistic insights gained throughout these 3 aims will finally be exploited for efforts to
generate human iMPCs. Collectively, our project will provide fundamental insights into the mechanisms
by which transcription factors and external signals rewire cell fate using the muscle lineage as a model
system and explore how this knowledge could be used in a therapeutic setting.
!

Public health relevance
NARRATIVE We have developed a novel strategy to dedifferentiate fibroblasts into induced myogenic progenitors (iMPCs) using a combination of MyoD expression and treatment with small molecules. To our knowledge, iMPCs represent the first expandable and engraftable myogenic cell population with stem/progenitor cell characteristics derived directly from unrelated, differentiated cells. We expect that iMPCs will provide a powerful system to study the mechanisms of cell fate change including muscle development and disease. In three complementary aims, we propose to (i) define the molecular and functional similarity of primitive (Pax7+) iMPC subsets to satellite cells in vivo, (ii) dissect the genetic and epigenetic mechanisms underlying this dedifferentiation process, and (iii) investigate the potential utility of iMPCs to study and treat dystrophy, including an effort to generate human iMPCs. !